Investigating the role of neddylation in the repair of topoisomerase I inhibitor-induced replication damage in colorectal cancer

PROJECT SUMMARY
Colorectal cancer (CRC) is one of the most lethal cancers. The topoisomerase I (TOP1) inhibitor irinotecan
is a major component of the current chemotherapeutic regimens for treatment of CRC. TOP1 is an enzyme
that resolves DNA topological issues by transient DNA breakage. TOP1-DNA cleavage complexes (TOP1ccs)
are covalent protein-DNA intermediates formed during TOP1 activity. Clinically active TOP1 inhibitors convert
the transient TOP1ccs into long-lived TOP1 DNA-protein crosslinks (TOP1-DPCs). TOP1-DPCs interfere with
DNA metabolic processes and induce cell death. Cells can repair TOP1-DPCs using mechanisms such as the
ubiquitin-proteasome system (UPS), and enhanced repair capability can result in reduced clinical efficacy of
TOP1 inhibitors. Targeting the UPS-dependent repair may improve the therapeutic benefits of TOP1 inhibitors.
Following high-throughput screens in CRC cells, I identified pevonedistat, a NEDD8-activating enzyme
inhibitor, as a cytotoxic agent inducing synergistic cytotoxicity with irinotecan and other TOP1 inhibitors. I also
found that inhibition of NEDD8 modification (neddylation) blocked the proteasomal degradation of TOP1-DPCs.
I hypothesize that the DDB1-CUL4-RBX1 complex (CRL4), a ubiquitin E3 ligase that is activated upon
neddylation and is important for DNA replication and repair, ubiquitylates TOP1-DPCs leading to their
degradation. I found that DCAF13, a DDB1-CRL4 associated factor, binds to TOP1 and is required for TOP1-
DPC ubiquitylation, suggesting that DCAF13 recruits TOP1-DPC to CRL4. I will systematically assess this
hypothesis and its implications during this award via three specific aims. During the K99 phase, I will work
closely with my mentor, Dr. Yves Pommier, a world-renowned expert in topoisomerases and cancer
chemotherapy. During my K99 training, I will assess the combination of irinotecan plus pevonedistat in CRC
patient-derived preclinical models (Aim 1). In specific aim 2, I will determine if the CRL4 complex acts as a
ubiquitin ligase for TOP1-DPCs and determine if DCAF13 is sufficient to recruit TOP1-DPCs for CRL4-
mediated ubiquitylation. In addition, I will study the mechanism by which neddylation activates the CRL4
complex for TOP1-DPC repair. Work in aim 2 will continue the independent R00 phase of this grant. A major
goal for this latter phase will be to determine CRL4-targeted ubiquitylation sites on TOP1-DPCs using mass
spectrometry. These results will be important for understanding mechanisms the allow cells to distinguish
between TOP1ccs and long lasting TOP1-DPCs Further experiments in the R00 phase (Aim 3) will interrogate
the role of neddylation in the repair of TOP1-DPC-induced DNA double-strand breaks (DSBs) during
replication in CRC cells. I will determine if neddylation modifies histones to recruit factors involved in
homologous recombination (HR) and if neddylation modifies p53 to enhance p53-regulated HR gene
expression to facilitate the DSB repair. Thus, support through the K99/R00 award will be instrumental in
completing this important research and will help me successfully transition as an independent researcher.

Public health relevance
PROJECT NARRATIVE Generation of topoisomerase I DNA-protein crosslinks (TOP1-DPC) is the therapeutic mechanism of TOP1-targeting anti-cancer agents, but how cells respond to TOP1-DPC remains unclear. Investigation of mechanisms repairing TOP1-DPC is therefore needed to characterize the guiding principles of cellular response to TOP1-DPC, and targeting these mechanisms could be developed to circumvent cancer resistance to TOP1 inhibitors. The proposed project is of paramount importance to patient care, ameliorating therapeutic strategies and, therefore, highly relevant to public health.